MORPHOLOGIC STUDIES OF NEURONAL AND NON-NEURONAL CELLS IN CNS CELL CULTURES

Axonal, dendritic, or synaptic structures were identified by immunohistochemistry in developing neuronal cultures. In cultures where electrical activity was suppressed, axonal and synaptic structures were more abundant than in active cultures. A methodology has been developed for the preparation of a multicompartment ventral horn neuron / hindlimb muscle cultures. Functional neuromuscular connections are formed, and the effect of electrical activity on the development and maintenance of such connections can be evaluated physiologically and morphologically.